Small Molecule Protease Inhibitors against MERS-CoV

PROJECT SUMMARY
Since the unexpected emergence of Middle East Respiratory Syndrome coronavirus (MERS-CoV) in 2013, the
ongoing outbreaks of MERS in the Middle East and the potential for global transmission of MERS, exemplified
by an outbreak in South Korea in 2015, have underscored the urgent need for effective preventive and
therapeutic measures against this highly virulent coronavirus. MERS-CoV expresses two polyproteins that
undergo proteolytic processing by two virus-encoded proteases, a 3C-like protease (3CLpro) and a papain-like
protease, to generate functionally active proteins. MERS-CoV 3CLpro processes the majority of the cleavage
sites on the polyproteins and is essential for viral replication, making it an attractive therapeutic target. A series
of potent dipeptidyl inhibitors of the 3CLpro of coronaviruses including MERS-CoV and infectious peritonitis
coronavirus (FIPV), a highly virulent feline coronavirus, have been generated. Using FIPV as a model, it was
demonstrated that the lead compound for FIPV reverses the progression of fatal FIP in experimentally or
naturally infected cats. Since FIP disease progression is quite rapid and its pathogenesis primarily immune-
mediated, features shared by MERS-CoV, it was hypothesized that a viral protease inhibitor could reverse the
pathogenesis of MERS-CoV in affected hosts. Using a structure-guided approach, the anti-FIPV compound
was structurally modified resulting in the identification of piperidine-derived lead compounds that were found to
be highly effective against MERS-CoV. Thus, the primary goal of this R01 application is the identification of an
in-vivo validated MERS-CoV preclinical candidate by conducting an array of basic and applied studies. Four
aims are proposed to achieve this objective. Specific Aim 1. Optimize the piperidine-derived lead series of
MERS-CoV 3CLpro inhibitors by iterative medicinal chemistry and structure-based drug design. Specific Aim 2.
Conduct in vitro efficacy, biochemical, mechanistic, structural, spectroscopic, and computational studies to
prioritize analogs, elucidate the mechanism of action, and accelerate the optimization process. Specific Aim 3.
Evaluate the physicochemical properties, ADMET, PK, and oral bioavailability of optimized leads. Specific Aim
4. Determine in vivo efficacy of optimized leads in mouse models of MERS-CoV infection. The ultimate long
term goal of this program is the development of antiviral therapeutics for MERS by advancing a drug candidate
through the stage of filing for an investigational new drug (IND) application.

Public health relevance
PROJECT NARRATIVE There is currently an urgent and unmet need for the discovery and development of antiviral therapeutics for the treatment of Middle East respiratory syndrome coronavirus (MERS-CoV) which constitutes an important health problem as well as a potential bioterrorism threat. The aim of this project is to conduct a lead optimization campaign aimed at advancing the series of protease inhibitors against viral protease to a preclinical drug candidate, which will have a significant impact on MERS-CoV research and public health.